Shared Resource Management

PROJECT SUMMARY – Shared Resource Management
The ACC Shared Resources provide access to specialized technologies, services, training and expertise
critical to accelerate research productivity for the 324 ACC members. Each Shared Resource engages with
ACC members, trainees, and staff to catalyze basic, translational, clinical and population science cancer
research, provide user training and support grant applications for extramural funding and publication of high
impact papers. Under the direction of Dr. Celeste Simon, Associate Director for Shared Resources, they are
continuously evaluated to ensure that they provide cutting edge technologies and accessible, cost-effective
and reliable services that serve the needs of the ACC membership. We propose the following three aims: 1)
Support high quality Shared Resources that serve the scientific needs of the ACC membership and catalyze
impactful research activity; 2) Ensure stability of and access to ACC and institutional Shared Resources
through responsible fiscal management and over-arching usage policies; and 3) Determine the scientific
priorities of ACC members and ensure current and future Shared Resources meet membership needs. ACC
Administration works closely with ACC Leadership and Dr. Simon in assessing Shared Resources, overseeing
management, and ensuring fiscal stability, cost-effectiveness and opportunities for growth. Fiscal oversight of
Shared Resources is accomplished through a suite of applications (Path BioResource system), centrally
managed by the Perelman School of Medicine (PSOM) and ACC Administration. Strategic planning is regularly
undertaken; user feedback and internal advisory boards for each Shared Resources guarantee cutting-edge
quality. The percentage of ACC users for each Shared Resource ranges from 32%-100%; the percentage of
annual budget support provided through CCSG to support each Shared Resource ranges from 7% to 34%. For
the current funding period, we are proposing nine Full Shared Resources – ACC BioRepository, Biostatistics
and Bioinformatics, Comparative Pathology, Flow Cytometry and Cell Sorting, Genomic Analysis, Human
Immunology, Metabolomics, Small Animal Imaging, and Transgenic and Chimeric Mouse Facilities. Based on
our strategic planning process and in response to members' scientific needs, two of these Shared Resources
(ACC BioRepository; Metabolomics) are new, each emerging from Developing Shared Resources of the
current funding period. One existing Shared Resource has been expanded in scope (from the Biostatistics
Core to the Biostatistics and Bioinformatics Core). Two Developing Shared Resources (Small Animal Radiation
and Electronic Phenotyping) are being proposed, based on ACC membership needs. ACC members can utilize
over 75 Core Facilities at PSOM; 24 of these undergo formal review by the PSOM Biomedical Research Core
Facilities Committee to assure quality. Through ACC support of Shared Resources, members have access to
state-of the-art equipment and instrumentation, technical expertise, training and education, all designed to
support innovative cutting-edge cancer research.